Network Core

ABSTRACT FOR THE NETWORK CORE
The VISION of the Northwest COmprehensive Research Training in Kidney, Urologic and Hematologic
Diseases (NCOR-KUH) Program is to train the next generation of KUH scientists who will drive scientific
innovation to improve the lives of patients with KUH diseases. The GOALS of the NETWORK CORE are to
address two major deficiencies in the current model of research training: the lack of a research community for
trainees and an endangered pipeline of future KUH scientists.
Silos in research training disconnects trainees from their peers, reducing engagement and peer support as well
as limits opportunities for collaborative science. To address this deficiency, the first goal of the Network Core is
to build a shared scientific community for trainees within the NCOR-KUH program (Aim 1) by employing the
following strategies. (1) A facile and interactive Virtual Platform and website will be developed to offer shared
resources and facilitate peer interactions. (2) A robust research training community for NCOR-KUH trainees will
be built by shared networking activities (e.g. retreats, research symposia, social events and community events)
to complement other career and professional development. (3) A tiered mentoring system will be created to
offer peer and near-peer mentors. (4) Further, we will bring together trainees from other training programs (e.g.
other T32s), by hosting shared symposia and social events. A second goal of the Network Core is to create
KUH research exposure programs for early learners (Aim 2), including high school students, college students,
medical students and residents. This will be accomplished by partnering with existing successful outreach
programs to add KUH specific research experience. We will utilize a new dedicated endowment from the Mt.
Baker Foundation ($500,000) to recruit those from underrepresented backgrounds specifically.
We have assembled a strong leadership team for the Network Core who have demonstrated success in KUH
mentorship, research, education, community building and outreach. This leadership is comprised of expertise
in K-U and H science and is purposefully diverse with 50% from underrepresented racial backgrounds or 1st
generation college graduates. These leaders will work collaborative with the other Core leaders and serve on
the Steering Committee to achieve the goals of the Network Core and the overall NCOR-KUH Program.

Public health relevance
PROJECT NARRATIVE Please see the Overall Core for the project narrative encompassing all cores.